The role of IL-37 in human regulatory T cells

PROJECT SUMMARY/ABSTRACT
Understanding peripheral tolerance and the maintenance of immune system homeostasis are vital in the
control of human diseases. We have previously demonstrated that anti-inflammatory cytokine IL-37
participates in immune tolerance by generating semi-mature tolerogenic dendritic cells (DCs) in antigen-
specific adaptive immune responses. IL-37 is one of eleven IL-1 family members and the only known member
to be broadly anti-inflammatory. In our recent project, we found IL-37 levels were elevated in multiple human
immune cell types, specifically in regulatory T cells (Tregs) cells. Further analysis revealed that human Treg
cells express the highest IL-37 levels among all T-cell subsets and that intracellular expression of IL-37
correlates with the expression of master transcriptional regulator, FOXP3, in human Treg cells. Our current
project hypothesizes that elevated IL-37 expression stabilizes Treg cells and induces potent immune
suppression by controlling FOXP3 expression. IL-37 is not expressed in mice, but using transgenic mice and
peripheral blood T cells from human donors, we generated strong preliminary data to support our hypothesis.
In this grant proposal, we will use human primary Treg cells and T cell lines overexpressing IL-37 and its
mutant form to elucidate the biological and molecular mechanisms of IL-37 in controlling human Treg cell
function. Since our proposal uses human T cells, the results could be easily translated into clinical medicine
and patient care. Our findings will have an immense translational impact on many human diseases such as
autoimmunity and transplantation.

Public health relevance
PROJECT NARRATIVE Immune tolerance is vital in preventing immune dysregulation and autoimmunity. This project describes an anti-inflammatory cytokine, IL-37, critical in maintaining the function of immunosuppressive regulatory T cells (Tregs) in humans. We will investigate the mechanisms of IL-37-induced immune suppression in human Tregs as possible targets for clinical applications.